Traumatic stress and binge drinking as risk factors for excessive alcohol intake

Post-traumatic stress disorder (PTSD) is classified as a trauma- or stressor-related disorder, and evidence
confirms an association between PTSD and the development of an alcohol use disorder (AUD). Despite
heterogeneity in the incidence of PTSD, high comorbidity of PTSD and AUD are reported in the veteran
population. Furthermore, the exacerbation of symptoms in veterans with comorbid PTSD/AUD negatively
influences recovery prognosis and effective therapeutic strategies. We and others found that exposure to
predator odor stress (PS), used as an animal model of PTSD, significantly increases anxiety-related behaviors
and subsequent alcohol (ethanol) intake in rodents. Most importantly, we observed heterogeneity in these
behavioral responses, as is observed in human PTSD/AUD patients. Additionally, prior binge drinking (BD)
produced a greater enhancement in ethanol drinking following intermittent PS in stress “sensitive” mice.
Specifically, “PS-sensitive” male and female C57BL/6J (B6) mice exhibited > 70% increase in ethanol intake (>
2.5 g/kg over baseline), while ethanol intake was unchanged in “resilient” mice. Additional studies in B6 mice
determined that BD alone produced sexually divergent changes in signaling pathways in the nucleus
accumbens (NAC), while the enhanced ethanol intake following BD and PS produced sex differences in
proteins related to the stress axis and neurosteroid synthesis in prefrontal cortex and hippocampus (NAC not
examined in that study). In conjunction with evidence for separate behavioral and epigenetic adaptations
underlying stress “sensitivity” and “resilience”, we hypothesize that: (1) distinct behavioral and molecular
adaptations confer “sensitivity” and “resilience” to the enhancing effect of BD and PS on later ethanol
drinking, (2) BD induces DNA methylation (DNAm) signals and associated changes in gene
expression that alter adaptability to PS, and (3) sex differences exist in the underlying mechanisms
in B6 mice. Aim 1 studies will determine whether “sensitivity” vs “resilience” to PS-enhanced drinking after
prior BD is associated with altered anxiety-related behavior, heart rate (HR), and/or ethanol reward and
whether sex differences exist in these relationships. Four groups will be tested: Group 1 (BD+4 weeks 23 h
ethanol drinking with intermittent PS; divided into “sensitive” and “resilient” subgroups); Group 2
(intermittent PS only); Group 3 (naïve); Group 4 (BD only). After the post-PS drinking (Group 1), final PS
(Group 2), or equivalent time point (Groups 3 & 4), HR and anxiety-related behavior will be assessed in one
study and conditioned place preference will be tested in a separate study. Aim 2 will identify epigenetic signals
and linked gene expression profiles in the NAC that confer “sensitivity” and “resilience” to PS-enhanced
drinking after prior BD. Groups will be as in Aim 1, but mice will be euthanized following final BD, post-PS
drinking, or final PS. We predict that the genome-wide DNAm analysis will identify differentially methylated
cytosines and regions mapping to novel and mostly distinct but some shared genes, regulatory regions, and
networks in males and females that will be associated with “sensitivity” and “resilience” to PS-enhanced
drinking. DNAm and gene expression association analysis will be integrated with behavioral outcomes from
Aim 1 to pinpoint targets for functional analysis. Aim 3 will confirm the functional role of selected genes (Aim
2) important for “sensitivity” and “resilience” to PS-enhanced drinking and associated behaviors. Protein levels
will be confirmed by Western blots. Pharmacological studies will manipulate candidate molecules and
determine the effect on PS-enhanced drinking, BD, anxiety, and HR, beginning with 3 molecules identified
during current funding. Elucidating biological and molecular mechanisms that confer “sensitivity” and
“resilience” to escalated ethanol drinking following BD and traumatic stress can guide
pharmacological treatment strategies for AUD and PTSD, which likely differ in males and females
and represent important areas of focus in the effective treatment of our veterans.

Public health relevance
Alcohol use disorder (AUD), which is characterized by repeated binge drinking (BD) episodes, and post- traumatic stress disorder (PTSD) are highly comorbid and contribute to health problems in the US veteran population. Because BD and traumatic stress are two risk factors that can shift alcohol intake from recreational to problematic/excessive, the risk for developing PTSD/AUD is high among the increasing number of young adults with prior BD exposures that are joining the military. Thus, we developed an animal model where prior BD and repeated exposure to traumatic stress (a model of PTSD) significantly increased anxiety-related behavior and subsequent alcohol intake in male and female mice, with heterogeneity in the response as is seen in PTSD patients. This model will serve to determine biological and molecular mechanisms that confer “sensitivity” and “resilience” to escalated drinking following BD and traumatic stress exposure and guide treatment strategies for veterans with comorbid PTSD/AUD.